Functional Neuroanatomy Correlates of Worry in Older Adults

ABSTRACT R01 MH108509 [FINA - Functional Neuroanatomy Correlates of Worry in Older Adults] was designed to characterize the neurobiological pathways linking severe worry and emotion regulation processes in older adults. We recently applied for a competing continuation 2 R01 MH108509-06 [The RAW Brain - The Effect of Rumination, Anxiety and Worry on Aging and Dementia Risk]. Through the renewal we aim to identify the pathways through which the rumination, anxiety and worry (RAW) phenotypes contribute to accelerated aging and increased ADRD risk. The renewal aims to follow our currently well-characterized cohort of older adults, and we plan to add 150 new older participants, similarly recruited on dimensional measures of rumination, anxiety, and worry. We will repeat the assessments at two-year follow-up, giving us three time points for the original cohort and two time-points for the new cohort. This will allow us to identify and monitor over time the neural and biological pathways leading from RAW to brain and body aging. The total N proposed in RAW is 150 (FINA participants) + 150 new participants. In order to achieve the required design and power, the renewal study relies on the FINA cohort of 150 older adults. The COVID pandemic mitigation efforts have impacted the FINA grant tremendously, with significant delays and interruptions that limited the ability to progress the current research study. The proposed supplement will aim to continue the recruitment for an additional five months after the scheduled end of FINA (June 2021), which will allow us to reach the proposed N. The funds are specifically aimed to recover salaries paid during shutdown. This is crucial for both the successful analysis of data obtained during the current proposal (based on power calculations) but also for the success of the renewed proposal. This proposal is responsive to NOT-MH-21-120 as: 1) it is within the scope of the funded research; 2) FINA is in the last year of the award; 3) completion of enrollment and follow-up are critical for both the success of the current project as well as the proposed renewal. 1

Public health relevance
PROJECT NARRATIVE The original study explores the functional and structural brain changes related to worry in older adults. The current supplement requests five additional months of funding for salary support to overcome the interruption in recruitment during the COVID Pandemic.